Physical activity, physical function, and frailty in relation to cognitive impairment and AD/ADRD biomarkers in DPPOS

The goal of Project 4 is to study the interrelationships of physical activity (PA), lower extremity physical function
(PF), and frailty, with cognitive impairment and its underlying neuropathology in older adults in the continuum of
pre-diabetes (PreD) and type 2 diabetes (T2D) in the Diabetes Prevention Program (DPP) Outcomes Study
(DPPOS). PA is a common lifestyle target in T2D prevention and treatment and was a key component of the
lifestyle intervention in the DPP. Higher sustained PA levels are hypothesized to be associated with a lower risk
of cognitive impairment. PF decline and frailty, increased in older adults with PreD/T2D, are closely related to
PA, and are also associated with cognitive impairment. Thus, this project seeks to better understand the
individual and joint associations of PA, PF, and frailty with cognitive outcomes and underlying neuropathology
among persons with PreD/T2D. Our preliminary data show that lower PA and PF levels and higher frailty at
midlife are concurrently associated with poorer global and domain-specific cognitive function. We now propose
to examine the association among PA, PF, and frailty trajectories, across the mid- to late-life transition period,
with cognitive decline, mild cognitive impairment (MCI) and dementia, and with plasma and imaging biomarkers
of neuropathology. Further, we will evaluate (1) exercise-induced myokines as mediators, and (2) T2D-related
metabolic factors and complications as moderators and mediators. We will leverage >25 years of PA data, >15
years of PF and frailty data, and extensive metabolic phenotyping in the longitudinal framework of DPPOS among
participants (N = 1,979) expected to enroll in DPPOS-AD/ADRD. We will achieve our goal through the following
specific aims: (1) To relate PA, PF, and frailty trajectories, separately and jointly, to amnestic and non-amnestic
cognitive decline and risk of MCI and dementia (AD continuum vs. non-AD pathology as exploratory) in
PreD/T2D; 2) To relate PA, PF, and frailty trajectories, separately and jointly, to changes in plasma biomarkers
of amyloid (Aβ42/40 ratio), tau (phosphorylated tau 181 [ptau-181]), neurodegeneration (neurofilament light
[NfL]), and neuroinflammation (glial fibrillary acidic protein [GFAP]). Among participants with brain imaging (N =
650), we will relate PA, PF, and frailty trajectories to amyloid burden, cortical thickness, and cerebrovascular
disease; (3) To examine the association of PA, PF, and frailty with exercise-induced myokines (e.g., brain-
derived neurotrophic factor [BDNF], insulin-like growth factor 1 [IGF-1]) and the relationship of myokines with
cognitive outcomes examined in Aim 1 and biomarkers in Aim 2. (4) To explore whether glycemic burden,
vascular burden, microvascular/macrovascular complications, and peripheral inflammation moderate and/or
mediate the associations examined across aims 1-3; (5) Exploratory Aim: Aims 1-4 will also explore interactions
by APOE-ε4, sex, body mass index (BMI), original randomized treatment assignment, race/ethnicity, and
measures of cognitive reserve (e.g., education level).